Interstitial macrophages in cigarette smoke-induced small airway remodeling

PROJECT SUMMARY
Project Summary: This proposal describes a 5-year research training program that will develop Dr. Patrick
Hume into an independent basic and translational physician-scientist investigator. His long-term career goal is
to advance the fields of COPD and macrophage biology through the elucidation targets to block or repair the
development of small-airways disease in cigarette smokers. During this K08 Award, Dr. Hume will gain specific
career development training and mentorship closely aligned with an innovative research plan. He proposes to
study the role of Lyve-1 positive interstitial macrophages in the development of small airway pathology induced
by chronic cigarette smoke. Given the broad applicability to COPD, this work is directly relevant to the NHLBI.
Candidate: Patrick Human MD, PhD is a board-certified Pulmonary and Critical Care Medicine physician-
scientist at National Jewish Health in Denver, CO. His record of basic science research, Ph.D. training and
scientific publications demonstrates a firm commitment to a career as an academic clinician-scientist.
Training: The proposed career development plan augments Dr. Hume’s prior mentored research during his
undergraduate, doctoral, medical residency and fellowship training. He proposes to meet his short-term
objectives through an integrated combination of intensive mentoring by internationally renowned experts in
macrophage biology and COPD pathogenesis with didactic and hands-on experiences in (i) data analysis, (ii)
cell biology, (iii) hyaluronic acid signaling, (iv) scientific writing and presentation, and (v) laboratory leadership.
Mentor / Environment: Dr. Hume has close working relationships with highly experienced mentors and
collaborators who contribute expertise in macrophage and lung biology (Drs. Janssen and Petrache), COPD
pathogenesis and hyaluronic acid signaling (Dr. Petrache), matrix metalloproteinase biology and tissue
remodeling (Dr. Redente), creation of transgenic mouse models (Dr. Matsuda) and design-based stereology
(Dr. Smith). The proposed activities will be based at National Jewish Health, a top-ranked research institution.
Research Project: The primary objective of this proposal is to identify the mechanism by which peribronchial
interstitial macrophages (PBIMs) mediate airway wall remodeling and pathogenesis in response to chronic
cigarette smoke exposure. Specifically, our studies will test the hypothesis that Lyve-1 expressed on a subset
of PBIMs binds to hyaluronic acid resulting in matrix metalloproteinase 9 (MMP-9) production, leading to airway
wall remodeling and fibrosis. This will be tested in human and murine lung tissue using quantitative
morphometry and immunofluorescence, flow cytometry, in vitro models of hyaluronic acid signaling, and
transgenic animal models. In doing so, the specific relationships between Lyve-1+ PBIM recruitment, MMP-9
production, and airway wall remodeling will be elucidated.

Public health relevance
PROJECT NARRATIVE Cigarette smoking-related lung diseases like chronic obstructive pulmonary disease (COPD) remain a leading cause of death worldwide. We believe Lyve-1 positive peribronchial interstitial macrophages play a key role in promoting the pathologic thickening of the small airway walls in response to cigarette smoke and may be a potential therapeutic target to intervene in COPD pathogenesis. We will test the hypothesis that matrix metalloprotein 9 production in response to Lyve-1 on the IM surface binding to hyaluronic acid promotes airway wall remodeling and fibrosis after prolonged cigarette smoke exposure.